Investigating virus-host interactions with prime editing and genetic code expansion

PROJECT SUMMARY
Host proteins play essential roles in the replication of all viruses. This represents a vulnerability that could
potentially be exploited to develop interventions against viruses currently circulating in humans as well as new
and emerging viral threats. However, realizing this potential requires mechanistic understanding of how specific
host factors function during viral infection. This proposal will develop a versatile screening methodology to
investigate the mechanisms through which host proteins enhance virus replication. This will be achieved using
recent developments in genome engineering and chemical biology that enable site-specific modification of host
factors with unnatural amino acids. By genetically re-coding >100 host proteins implicated in the replication of
influenza A virus (IAV), we will investigate (1) the effects of depleting specific host factors on virus replication
and the subcellular localization of viral proteins; (2) the effects of viral infection on the expression and subcellular
localization of host proteins; and (3) the effects of host factor depletion on the assembly and morphogenesis of
new virus particles. If successful, this project will provide insight into the host dependency of IAV and establish
a resource for investigating host protein function in the replication of additional, evolutionarily-divergent
respiratory viruses.

Public health relevance
PROJECT NARRATIVE Therapeutic interventions that can prevent or control emerging viral infections are urgently needed. One approach to developing these interventions is to target proteins from the host that function to enhance viral infection, rather than targeting the virus directly. By contributing to a better understanding of how specific host proteins contribute to viral replication, the proposed research will accelerate the development of host-directed antiviral therapies.